The OPTIMIZE Study: Optimizing Patient Navigation for Perinatal Care

Persistent and worsening racial and ethnic disparities in maternal and infant outcomes in the US are urgent
public health concerns. African American (AA) women have about twice the risk of preterm birth and low
birthweight compared with non-Hispanic white women and are more likely to suffer from complications of
pregnancy and severe maternal morbidity. As these disparities worsen, there has been renewed focus on
perinatal care. The perinatal period, those weeks before and after birth, has important implications for a woman's
health and that of her child. Unfortunately, the prevailing perinatal standard care model has been stagnant for
decades and is not meeting the needs of AA women, especially with consideration to Social Determinants of
Health (SDH) and the `fourth trimester' postpartum period proposed by the American College of Obstetricians
and Gynecologists (ACOG). Patient navigation (PN) has demonstrated efficacy in improving consistency of care
and addressing SDH among AA women. However, traditional PN models are economically challenging to scale
and sustain, suggesting that a PN paradigm shift is needed – one that minimizes the need for in-person
navigators and places greater focus on clinic and systems level care improvement that integrates local and
federally program support addressing SDH. Building on our decade of work in PN in women's health and care
coordination checklists, we propose to develop a learning health care delivery approach to PN centered around
an OPTIMIZE integrated and comprehensive perinatal care checklist. OPTIMIZE is highly aligned with ACOG
endorsement of checklists for enhancing processes of care and teamwork. Through a Hybrid type 1 cluster
randomized effectiveness-implementation trial, we will compare the effectiveness of the OPTIMIZE intervention
relative to standard care in improving patient receipt of integrated and comprehensive perinatal care (prenatal
content, postpartum content, and SDH content) tailored to a woman's individual needs, while evaluating
intervention implementation. N=600 AA women in their 1st or 2nd trimester of pregnancy will be recruited from 20
clinics affiliated with two community health center networks that provide the majority of perinatal care for AA
women in Chicago. Clinics will be randomized 1:1 to standard care (control) or standard care plus OPTIMIZE
checklist with PN support (intervention) starting from the initial prenatal visit and through 12-weeks postpartum.
The OPTIMIZE checklist will scale the reach of navigators by facilitating coordination and integration of efforts
across perinatal care domains and integrating a SDH orientation to perinatal care. The checklist, tailored to the
workflow within each clinic, will contain prenatal, postpartum, and SDH content for each patient. The primary
outcome is patient receipt of perinatal care components in these 3 content areas collected by medical records
review. Secondary outcomes include depressive symptoms, breastfeeding, vaccine (Tdap, influenza, HPV) and
contraception uptake. The Consolidated Framework for Implementation Research will guide our mixed-methods
approach to evaluate intervention implementation and identify implementation facilitators and barriers.

Public health relevance
PROJECT NARRATIVE African American women and their infants experience profound perinatal health disparities in the US, and these are even more striking in Chicago. We hypothesize that an integrated and comprehensive perinatal care checklist with patient navigation support may help address these disparities, in particular by increasing patient receipt of prenatal care content, postpartum care content, and local and community resources to address social and economic issues. We propose to test this hypothesis by conducting a pragmatic, randomized trial in community health centers to evaluate the effectiveness and implementation of the checklist strategy.